BLOOD GLUCOSE AWARENESS TRAINING--ENHANCEMENT AND EXTENSION

Study to assess the disruptive effects of hypoglycemia on cognitive, perceptual, motor and driving skills. Thirty IDDM and 10 controls will undergo insulin infusion and be tested at 5 blood glucose levels. Ten additional IDDM controls will be tested 5 times at euglycemia. The most and least affected IDDM subjects will be retested in two months.